APOL1 Nephropathy: Linking Genetics and Mechanisms

SUMMARY:
Two coding variants (G1 and G2, also referred to as "risk variants" or RV) in the APOL1 gene account for much
of the high rate of kidney disease in people of recent African ancestry. Evidence supports the idea that APOL1
risk variants (RV) promote kidney disease through toxic, gain-of-function activity despite a largely recessive
pattern of risk inheritance. Investigators have speculated that recessive gain-of-function toxicity may be due to
a dose threshold requiring two risk alleles or alternatively a “G0 rescue” model where G0 can protect against
the toxic effect of the risk variants, potentially via direct interaction. The work proposed here will provide insight
into this fundamental question of recessive, gain-of-function biology that is essential for understanding the
mechanisms of APOL1 disease. We have generated a series of APOL1 BAC transgenic mice to study the
mechanism of APOL1 kidney disease in vivo. RV mice respond to interferon, a powerful inducer of APOL1
expression, with robust proteinuria and foot process effacement while G0 mice develop neither. In Aim 1, we
will use a suite of hemizygous, heterozygous, homozygous, and multicopy BAC transgenic mice including both
G0 and risk genotypes to explore the relationship between gene dose and glomerular phenotype. We will
perform an in-depth molecular characterization just below and above the critical interferon dose that is
necessary for disease development. In Aim 2, we will explore the role of multimerization in APOL1-mediated
cytotoxicity. Oligomerization may be an essential step for APOL1 ion channel formation and APOL1 RV appear
more prone to multimerization than G0 APOL1 proteins. We will test the differential propensity of APOL1
genotypes to interact with one another and map the oligomerization domains. We will test the functional
consequences of multimerization both in cells and in vivo. In Aim 3, we will examine how interferon changes
APOL1 behavior and the cellular milieu to enhance toxicity, motivated by the observation that APOL1 kidney
disease often occurs in the setting of high interferon states such as HIV, COVID-19, and lupus. While
interferons trigger APOL1 kidney disease at least in part by upregulating APOL1 gene expression, our mouse
models indicate that factors beyond the high risk APOL1 genotype and increased expression may be required
for disease penetrance. We hypothesize that other interferon stimulated genes may enhance the toxicity of RV
or help mitigate the toxicity of G0. Alternatively, APOL1 may itself be modified by the interferon program
through expression of alternative transcripts, post translational modifications, or different trafficking patterns.
We will identify elements of the interferon-stimulated cellular milieu that may regulate the quantitative threshold
where APOL1 becomes toxic.

Public health relevance
8. Project Narrative Genetic variants in the APOL1 gene are a major contributor to the very high rate of kidney disease in African Americans and others of recent African ancestry, and also confer resistance to Sleeping Sickness in Africa. We want to better understand how these genetic variants lead to this major disparity in kidney disease at a biological level. Understanding how these differences in the APOL1 gene cause kidney disease will have direct implications for improving all aspects of care for the growing number people with this serious public health problem and ultimately removing a major racial health disparity.